Onco-Genomics Shared Resource

PROJECT SUMMARY: ONCO-GENOMICS SHARED RESOURCE
The Sylvester Comprehensive Cancer Center (Sylvester) Onco-Genomics Shared Resource (OGSR) offers
readily accessible, cost-effective, state-of-the-art technologies, services, and expert support for studying
cancer genomics and epigenomics, with cutting-edge platforms and applications not easily implemented in
individual investigator laboratories. The aims of the OGSR are to deliver 1) state-of-the-art genomics
technologies and services; 2) new services using emerging technologies; and 3) consultation and education on
genomics services and applications. The OGSR provides library preparation and next-generation sequencing
(NGS) services for genomics, epigenomics, transcriptomics, and metagenomics research; single cell and
spatial multiomics services; gene expression assays; and sample extraction, quantification, and quality
assessment. The facility has 14 major research instruments, including Illumina NovaSeq X Plus and NovaSeq
6000 sequencers; a nanoString GeoMx Digital Spatial Profiler; a 10x Genomics Chromium X single cell
controller; and PerkinElmer Zephyr and Hamilton Vantage high-throughput liquid handlers. OGSR personnel
work with members from all Research Programs to provide optimal NGS library synthesis and to enable the
sequencing of a wide range of library types. Working closely with other Shared Resources (SRs), the OGSR
supports coordinated project design and integrated workflows for projects that span multiple SRs, including
sample processing, data generation, and bioinformatic analysis. The OGSR also offers seminars and
educational workshops for members, trainees, and staff, covering existing and emerging genomics
technologies and applications. Ready access to OGSR services is provided via an online iLab portal. In
alignment with the goals of the 2019-2023 Strategic Plan, Sylvester provided continuous investment in the
OSGR. Over the current reporting period (6/1/2018-5/31/2023), ten new major instruments were installed, the
number of staff was increased from six to eight, and OGSR space increased 2.8-fold to 2,467 sq ft. During this
period, the OGSR provided services to 77 Sylvester members, who comprised 80% of total usage by revenue.
In addition, the OGSR contributed to 65 publications by members, of which 48% (31 publications) were in high-
impact journals (JIF ≥10). The OGSR supported 54 successful extramural cancer-related grant applications by
members, including 16 NCI awards. In light of the increasing complexity of cancer research, and in alignment
with the 2024-2028 Sylvester Strategic Plan, the future plans of the OGSR are to expand whole genome
sequencing for low-input and single-cell applications to facilitate studies of cancer heterogeneity; expand the
application of emerging spatial multiomics technologies to support tumor microenvironment and immuno-
oncology research; enhance genomics and epigenomics research by facilitating member access to new long-
read sequencing platforms and applications; and enhance effective data sharing, storage, access, and analysis
in support of transdisciplinary cancer research.